PILOT STUDY OF MK-0677 IN MUSCULOSKELETALLY-IMPAIRED ELDERLY

The purpose of this study is to compare the release of cortisol and prolactin (two hormones that are already being released in the body) before and after taking MK-0677. The study will also determine if the normal day to day pattern of the release of cortisol is being changed in any way by taking MK-0677. Thiss substudy will also tell the investigators if there is any change in the pattern of release of growth hormone. Growth hormone is also a natural hormone that occurs in the body and is released throughout the day and night.